Role of Base Excision Repair in Limiting Hepatocellular Carcinomas

Summary
The combination of chronic dietary exposure to the fungal toxin, aflatoxin B1 (AFB1), and hepatitis B viral (HBV)
infection is associated with a significant increased risk for early onset hepatocellular carcinomas (HCCs) in
millions of people living in East Asia, Central and South America, and sub-Saharan Africa. Even though dietary
exposures to aflatoxins constitute the second largest global environmental risk factor for cancer development,
there are still significant questions concerning the molecular mechanisms driving carcinogenesis. In-depth
knowledge of these mechanisms is critical for the identification of genetic risk factors that affect individual
susceptibility for people who are HBV infected and AFB1 exposed. In this regard, since AFB1 carcinogenesis is
driven by high frequency G to T transversions, the DNA repair pathways that initiate and complete repair of
persistent AFB1-induced DNA adducts and base damage from HBV-induced inflammation have strong
biological significance. These pathways define the mutagenic burden in the target tissues and ultimately limit
cellular progression to cancer. Although the nucleotide excision repair (NER) pathway has been shown to
repair AFB1 DNA adducts, murine data presented herein demonstrate that knockout of the DNA base excision
repair (BER) pathway, initiated by the DNA glycosylase NEIL1, is significantly more important than NER
relative to the removal of the highly mutagenic AFB1-Fapy-dG adducts. Thus, our data suggest that
deficiencies in NEIL1 could contribute to the initiation of HCCs in humans. To maximize relevance to human
health, all known variants of NEIL1 will be characterized from regions of the world where aflatoxin ingestion
and HBV infection are prevalent. All variants will be characterized for their biochemical properties relative to
WT NEIL1 and expressed in cells and transgenic mice to understand the potential for catalytically-
compromised variants of NEIL1 to alter susceptibility to aflatoxin exposures. These aims will test the
hypothesis that expression of the oncogenic and other catalytically-compromised variants of NEIL1 can
efficiently block repair and promote increased mutagenesis and carcinogenesis. Characterization of
phenotypically dominant oncogenic variants of NEIL1 will provide the molecular basis from which to design
human epidemiological studies in at-risk populations and early onset HCC cohorts. Further, this application
proposes to establish the molecular mechanisms by which the combination of chronic inflammation driven by
the hepatitis B surface antigen and deficiencies in DNA repair could synergistically drive AFB1-induced
mutagenesis and carcinogenesis. Overall, these studies have direct human health relevance pertaining to
understanding a global environmental health problem by identifying genetic risk factors and biochemical
pathways previously not recognized as germane to AFB1-induced carcinogenesis.

Public health relevance
Narrative Decades of investigations have established chronic dietary exposures to fungal toxins (aflatoxins) and chronic inflammation from hepatitis B viral infection as known risk factors for developing liver cancer. We have recently discovered an additional risk factor - deficiencies in a DNA base excision repair gene. Since at-risk portions of the human population carry deleterious mutations in this repair gene, this application will investigate deficiencies in this pathway as a driver of liver carcinogenesis using biochemical, cell, and murine models.